Bridging cell and organism scales to model viral, cell, and microenvironmental determinants of infection outcome

Research Project 2 (RP2) proposes to develop equation learning and model-constrained neural network
frameworks to bridge between spatially explicit cell scale models and individual scale models. Agent based
models (ABM) will be used to model the cell scale, while differential equation and stochastic process models will
be used to represent the individual scale. Crucially, we will then use modern deep learning approaches to build
individual scale models that incorporate information from bulk, single-cell, and spatial assays. We will use these
models to determine the viral, cellular, and spatial drivers generating atypical T-bet+ memory B cells (ABC) after
EBV infection, and precisely quantify conditions for HIV-1 reactivation in latently infected T cells in the lymph
node after administering latency reversing agent (LRA). The clinical importance of these questions is that ABCs
are a likely causal factor in the strong association between EBV and autoimmune disease, especially multiple
sclerosis, and our studies will contribute to insight about the pathogenesis of EBV-associated autoimmune
disuse, and LRA reactivation is a part of a major strategy for HIV cure, and hence this work will help define the
precise conditions under which latently infected cells can be reactivated in vivo. To develop the bridging
framework, we propose to characterize viral infection dynamics in lymphoid tissue cultures (Aim 1), construct
cell scale ABM to model spatiotemporal interactions between virus and host cells (Aim 2), and bridge cell to
organism scale models using equation learning and Biologically Informed Neural Networks (BINN) (Aim 3). We
will use tonsil explants for the EBV experiments, and a microfluidic lymph node on a chip system for HIV
experiments. For both experiments, we will perform various assays across multiple time points, including viral
loads, cytokine profiles, single-cell gene expression, and Co-Detection by Indexing (CODEX) spatial proteomics.
Next, ABMs based on the Vivarium software platform will used to model the spatiotemporal interactions between
the virus and host cells, seeking to replicate in silico the observed tissue dynamics. These models will be
initialized using data generated by the lymphoid tissue culture experiments, including spatial single-cell CODEX
data and dynamic viral loads. The calibrated model will be used to study outcome variation, explore
perturbations, and generate training data, particularly regarding dynamic cellular trajectories and their
multicellular interactions. Finally, we will use synthetic data sets generated by calibrated ABM models for
equation learning and training the BINN. This involves automatically learning and calibrating mathematical
models. Stochastic process models can be converted into partial differential equations or truncated ordinary
differential equations using the master equation approach and learned in the same way. If successful, the
bridging framework developed in RP3 will provide a process for automatic condensation of high-dimensional
ABM spatiotemporal dynamics into a set of low-dimensional parameterized equations, a process that might
otherwise take a graduate student in Mathematical Biology several years to accomplish.